NK cell exhaustion in metastatic melanoma

Project summary NK cells are key participants in the initial immune response to tumorigenesis and virus infections, equipped to respond rapidly through induction of cytokines and deployment of cytotoxic activity. A dynamic balance of positive and negative signals regulates NK cell target cell recognition and lysis, through engagement of a variety of activation and inhibitory receptors. However, as cancers advance there is accumulating evidence that NK cells become progressively dysfunctional. NK cell “exhaustion,” could explain the failure of NK cells to contain tumor growth in advanced cancers. While NK cell hyporesponsiveness has been described in various malignancies, there is little characterization of an “exhausted NK cell state” in metastatic disease, nor of the mechanisms that might underlie this phenotype. We now have evidence that NK cells progressively undergo exhaustion in late stage melanoma. Melanoma associated NK cells are characterized by a failure to proliferate, to produce interferon gamma (IFNγ) or to kill target cells. They (i) down regulate activation receptors, IL-2R subunits and NK cell regulatory transcription factors (T-bet, Eomes), (ii) upregulate inhibitory receptors and (iii) express high levels of the checkpoint molecule Tim-3, a phenotype that is consistent with “NK cell exhaustion”. Significantly, blockade of Tim-3 substantially reverses this phenotype and state of exhaustion in vitro (Can. Imm Res. 2014). Most strikingly however, we find that patients who have a clinical response to ipilimumab treatment spontaneously restore their NK cell function, despite the fact that these cells express little or no CTLA-4 (or PD-1 or PD-L1), possibly through reversal of tumor-associated systemic immune suppression. Characterizing NK cell dysfunction in melanoma, therefore, will be critical to understanding the modulation of NK cell biology in the tumor microenvironment (TME), and ultimately towards developing approaches that restore both innate and adaptive immunity, in vivo. Although the survival of advanced melanoma patients (stage IV) has been extended by interventions that reverse T cell exhaustion, we hypothesize that reversal of exhaustion in NK cells will contribute towards the full restoration of immune responses that are required to eliminate melanoma cells. To address this hypothesis, we aim to define the spectrum of NK cell exhaustion in melanoma and identify molecular/protein targets that potentiate NK cell exhaustion (Aim 1). Secondly, we will determine if NK cell exhaustion can be reversed in response to checkpoint blockade inhibition, and identify associated biomarkers (Aim 2). In Aim 3, we will develop murine models to define and test interventions that reverse NK cell exhaustion. Characterizing NK cell dysfunction in melanoma will be critical towards developing approaches that restore immunity, in vivo.

Public health relevance
Project narrative We now have clear evidence that NK cells progressively undergo a process of “exhaustion”, described as a state of cellular dysfunction, from early to late stage melanoma. Characterizing NK cell dysfunction in melanoma will be critical towards developing approaches that restore immunity, in vivo.